VISTA-Mediated Immune Evasion in High-Risk Myelodysplastic Syndrome

Project Summary/Abstract
Myelodysplastic syndrome (MDS) is a hematologic disorder characterized by ineffective hematopoiesis,
cytopenias, and a risk of progression to acute myeloid leukemia (AML). While immune dysregulation is seen
almost universally in MDS, studies have observed immunologically distinct phenotypes in low-risk (LR-) or high-
risk (HR-) MDS. Inflammation is often seen in LR-MDS while HR-MDS is associated with immune suppression.
For example, HR-MDS has been associated with an increased frequency of inhibitory myeloid-derived
suppressor cells (MDSCs) and a skewing of macrophages towards anti-inflammatory (M2-like) phenotypes.
However, how these contrasting immune profiles influence MDS pathogenesis and progression is not well
understood, and efforts to target immune suppression in HR-MDS with available immune checkpoint inhibitors
(such as anti-PD-1/PD-L1 therapy) have had limited success, indicating the presence of other immune
suppressive mechanisms. VISTA (V-domain Ig suppressor of T cell activation, also known as PD-1H) is a co-
inhibitory checkpoint molecule known to suppress the inflammatory activation of both T cells and myeloid cells.
In myeloid cells, VISTA can promote M2-like characteristics in macrophages and mediate the immune
suppressive functions of MDSCs. Our group recently reported that myeloid-expressed VISTA is a significant
contributor to AML immune evasion in vivo. In my preliminary studies, I have found that VISTA is overexpressed
in HR-MDS, particularly by monocytes and macrophages, but how this VISTA expression influences the immune
microenvironment in HR-MDS and regulates MDS immune evasion is unknown. Therefore, this proposal will
test the hypothesis that VISTA expression by host immune cells promotes MDS immune evasion in high-
risk MDS. Aim 1 will use spectral flow cytometry (CyTEK) and highly-multiplexed immunofluorescence (CODEX)
to profile and spatially resolve the bone marrow microenvironment of LR-MDS and HR-MDS. These studies
would help to clarify the role of VISTA in HR-MDS and identify cell-cell interactions mediated by myeloid VISTA.
Aim 2 will further investigate the role of myeloid and macrophage VISTA in MDS. In vitro experiments will reveal
the VISTA-mediated mechanisms of macrophage anti-MDS immunity while in vivo experiments will assess the
impact of myeloid VISTA on MDS progression and immune evasion using a myeloid-specific conditional
knockout (LysM-Cre+;VISTAfl/fl). Finally, ex vivo experiments will validate the role of VISTA in human MDS and
test the utility of anti-VISTA antibody blockade in the treatment of HR-MDS. Together, the studies in this proposal
will deepen our understanding of how immune dysregulation facilitates MDS disease progression and help
elucidate the immune suppressive mechanisms present in HR-MDS, providing a preclinical basis for the
development of VISTA antagonists to treat high-risk MDS. Furthermore, funding of this fellowship application will
provide comprehensive scientific training in basic and translational cancer immunology and outstanding career
mentorship for a future hematology-oncology physician-scientist.

Public health relevance
Project Narrative Myelodysplastic syndrome (MDS) is a blood disorder more common in elderly patients with about a 30% risk of transformation into acute myeloid leukemia (AML). While immune cells, including T cells and macrophages, normally play a key role in the clearance of dysplastic bone marrow cells, such as those found in MDS, the immune system is often suppressed in high-risk MDS, thus allowing for disease progression. This proposal will investigate the immune suppressive effects of the novel checkpoint protein, known as VISTA (V-domain Ig suppressor of T cell activation), in high-risk MDS with the aim of identifying a new, much-needed therapeutic target for patients with high-risk MDS.